STK25 phosphorylates PRKAR1A to regulate PKA signaling

Project Summary
The development of new therapies in heart failure is a critical need and current drug development in this field is
not sufficient to keep pace with the increasing incidence and mortality of this disease. Novel therapeutic targets
are required as are model systems that more closely resemble human cardiac physiology. Protein kinase A
(PKA) is a cAMP sensitive kinase that is the central relay for beta-adrenergic stimulation of cardiomyocyte
contraction and calcium flux. With a broad set of substrates, specificity of signaling relies on careful regulation
of both cAMP metabolism and kinase activity. Regulatory subunits of PKA both inhibit kinase activity and help
recruit effectors and macromolecular binding partners to orchestrate kinase signaling. Type I regulatory subunits
are broadly expressed yet how their function is modulated is not well known. In recently published work, we
demonstrate that the Type Iα regulatory subunit (PRKAR1A) is phosphorylated by the kinase STK25. In studies
performed in human induced pluripotent stem cell derived cardiomyocytes (iPSC-CM), phosphorylation of
PRKAR1A led to inhibition of PKA kinase activity and downstream signaling in response to cAMP through
increased binding to the catalytic subunit. Knockout studies of Stk25 in mice confirmed its in vivo role of inhibiting
PKA activity. In further preliminary data, the Stk25 knockout was associated with improved outcomes after
myocardial infarction with decreased fibrosis and increased cardiac function. In a set of logical and feasible
aims, we propose to tests the hypothesis that STK25 phosphorylation of PRKAR1A leads to inhibition of PKA
activity and that this signaling between STK25 and PRKAR1A has therapeutic potential. In Aim 1, we use
genetically modified iPSC-CM’s to investigate the mechanism of how phosphorylation leads to increased
inhibition of PKA activity as well as characterize the changes to the macromolecular PKA complex in response
to phosphorylation of PRKAR1A. In Aim 2, transgenic mice with knock-in mutations are utilized to investigate
Prkar1a phosphorylation and its regulation of PKA activity in vivo. In the third aim, an inducible conditional
knockout of Stk25 is generated in mice and is used to explore the mechanism underlying the improvement after
myocardial infarction in response to loss of Stk25. We will examine if loss of Stk25 after a myocardial infarction
imparts any benefit and whether a decrease in Prkar1a phosphorylation mediates this improvement. We also
will investigate a novel inhibitor to explore the pharmacologic potential of targeting this pathway after myocardial
infarction in vivo. We believe that this proposal will have significant impact on our understanding of PKA
regulation in cardiomyocytes and establish the phosphorylation of PRKAR1A as a as a potential therapeutic
modality in myocardial infarction and heart failure.

Public health relevance
Project Narrative Cardiovascular disease is the leading cause of death worldwide and new therapies are needed to treat this very prevalent disease. We have identified a protein called STK25 that is able to downregulate one of the central signaling pathways that controls how strong the heart is able to contract. We propose to study how this protein is able to regulate cardiac function and whether this new relationship has therapeutic potential in heart failure.